Patient-Specific Simulation for Surgical Rehearsal

DESCRIPTION (provided by applicant): This project will develop and validate technology that will provide surgeons with new and powerful means to examine and interact with preoperative patient data -- in a manner that will improve patient safety, increase surgeon confidence, shorten procedure times, and improve outcomes. Our underlying hypothesis is that, by providing surgeons with a high-fidelity interactive simulation environment in which they can visually and physically interact with very realistic patient-specific simulations, that they will be able to plan and then rehearse a patient's procedures with sufficient immersion that performing the actual procedure will feel familiar and can be performed with confidence, precision and improved outcomes. These broad goals will be achieved by accomplishing four underlying aims including 1) the design and development of a visuohaptic workstation (enabling stereo visual and haptic touch interactions with the medical simulations) and creation of advanced haptic rendering algorithms to enable interaction of virtual tools with detailed patient-specific anatomy (derived from volumetric image data), 2) the development methods for photo-realistic rendering of large volumetric datasets acquired from patient-specific clinical imaging (including realistic rendering of translucent bio-materials and wet surfaces) to portray subtle visual cues essential for making surgical decisions, 3) the development methods for real-time, physics-based simulation of interactions between rigid bodies, and deformable tissues (including models and algorithms needed to simulate surgical manipulations such as retraction, incision and resection). In achieving these first three aims we will create a cost-effective visiohaptic workstation for rehearsal by exploiting emerging multi-core and graphics processing units, and high quality graphics and haptic displays, the costs all of which benefit from increasing consumer demand and technical breakthroughs. Finally, our fourth aim will be to assess the accuracy and utility of our patient-specific surgical rehearsal environment for use in cranial-base surgery (focusing on procedures limited to the poster lateral and anterior cranial base) and validate our hypothesis by study of i) subjective realism and ease of use, ii) ability to predict exposure of critical anatomy, and iii) its impact on surgical cases.

Public health relevance
Project Narrative It is common for a doctor today to carefully study diagnostic images prior to embarking on a clinical procedure. Even 50 years ago, though the quality of early X-ray images was poor, from the very beginning provided and will continue to provide life-saving guidance. With the ever increasing quantity and quality of diagnostic information available, it is easy to see how doctors could become overwhelmed with all the data. This project will take the next important step in enabling doctors to interact effectively with highly dense sources of 3D information; by enabling them interact in real- time with physical models of their actual patients, using their visual and touch abilities. Enabling doctors to plan different approaches to a procedure and then rehearse the actual procedure before entering the operating room promises to provide new levels of assurance and success in the surgical treatment of disease, restorations, trauma and more. __SpecificAimsTextDelimiter__ Specific Aims The goal of the project is to create patient-specific simulation technology that will enable clinicians to visually examine and physically interact with preoperative medical imaging data to predict intraoperative findings. This will enable surgeons to plan and rehearse specific procedures in a manner that will improve patient safety, increase surgeon confidence, shorten procedure times, and improve outcomes. In addition, we anticipate a demonstrable improvement in the care for each specific patient. Thus our work leads toward a new and sustainable business model for surgical simulation - in showing how individual outcomes and be improved by having the surgeon plan and rehearse a procedure with an interactive personalized patient model, we begin to show the health-care value of the technology and raise the potential for insurance reimbursability and other sustainable business models. Modern medical imaging provides preoperative knowledge of patient anatomy and pathology essential to a successful surgical intervention. It is how this wealth of information is presented to, and used by, the surgeon that determines the benefit in care that a patient will ultimately receive. Monumental advances in data processing and visualization technologies have occurred within the past decade, but little of it has been utilized to improve preoperative surgical care. We see surgical rehearsal as one such opportunity, and the goal of our proposed work is to bring simulation technology into the preoperative workflow, demonstrating the added value on a per-patient basis. Our specific aims are as follows: Aim 1: Design a visual and haptic workstation, composed of a two-handed haptic interface (each with seven degrees-of-freedom), a co-located high-definition stereo visual display, and sufficient computational resources to enable surgical manipulation of virtualized patient data. This includes design and prototyping of new, high fidelity haptic devices that are tailored for the control of virtual surgical instruments. Aim 2: Develop a virtual surgical environment enabling surgical rehearsal on patient-specific models derived from preoperative medical image data. The simulation environment will allow the surgeon to interact with a virtual model of the patient while reproducing, to the highest accuracy and fidelity possible, the visual and physical (haptic) stimuli the surgeon would encounter while performing the actual procedure. Aim 3: Assess the accuracy and utility of a patient-specific surgical planning and rehearsal environment for use in cranial-base surgery. Validation efforts will focus on procedures limited to the posterolateral and anterior cranial base. The complexity and variability of the anatomy in these procedures has a large impact on the surgical approach, and preoperative imaging can clearly identify the specific anatomy of a patient to inform the surgeon's approach. While the methods and technologies we propose to investigate and to use are not specific to a particular surgical discipline, we elected to use cranial-base surgery to guide our design, development, and assessment, for the reasons outline above. Our research team comprises a unique partnership of clinicians and scientists who will participate in all stages of the proposed work to ensure that the result will be a virtual surgical environment that is both effective and useful in a clinical workflow. Creating a virtual environment for patient-specific surgical simulation is a challenging technical endeavor, and necessitates key advances in photo-realistic rendering of medical image data, high-fidelity haptic interface design and rendering algorithms, and methods for manipulation of high-resolution volumetric models. We have assembled a team of investigators ideally suited to accomplish the aggressive goals we have set. Our technical approach will take advantage of emerging low-cost computational, haptic, rendering, and physical simulation technologies, many of which are inspired by the investigators' prior successes in this and related fields which, taken together, we expect will yield a highly functional and marketable results.